Discovering Drug-Like Probes for the α9α10 Nicotinic Acetylcholine Receptor

ABSTRACT
Approximately 1 in 10 adults in the U.S. experience neuropathic pain, which is pain caused by a malfunctioning
or diseased nervous system. Current treatments for neuropathic pain are only moderately effective and possess
serious side effects. Therefore, there is a need for new and safer treatments for neuropathic pain. The α9α10
nicotinic acetylcholine receptor (nAChR) has been proposed as a potential target for neuropathic pain. Previous
work has shown that α9-knockout mice exhibit decreased hyperalgesia in models of neuropathic pain.
Additionally, antagonism of the α9α10 nAChR with α-conotoxin inhibitors reduces allodynia and hyperalgesia in
rodent models. Despite this promising evidence supporting α9α10 as an analgesic target, current antagonists
have poor oral bioavailability, low metabolic stability, and are non-selective. Due to poor expression in
mammalian cells, previous studies of the α9α10 nAChRs have required the use of electrophysiology in oocytes,
which has limited the discovery of novel α9α10 ligands. However, our group has recently developed a cell line
that stably expresses α9α10, allowing us to identify and investigate new ligands for this receptor. My central
hypothesis is that the development of a novel, drug-like α9α10 nAChR selective probe can be used to further
the understanding of the α9α10 nAChR as a drug target. In Aim 1, I will use a structure-based approach to
convert AT-1001, a partial α3β4 nAChR agonist with moderate antagonist activity at the α9α10 nAChR, into an
α9α10-selective ligand. In parallel, Aim 2 applies a ligand-based approach with a lead compound identified from
a high-throughput screen recently conducted by our lab. The proposed structure-activity relationship studies will
focus on identifying a potent α9α10 antagonist. Upon identifying an improved α9α10 antagonist, the selectivity
of this compound will be evaluated at other nAChR subtypes and central nervous system receptors. This
research showcases two innovative approaches towards the development of a drug-like α9α10 nAChR selective
probe as it employs tools and strategies that have not been previously used to develop ligands for this receptor
and will advance the significance of the α9α10 nAChR in drug discovery.

Public health relevance
NARRATIVE The nicotinic acetylcholine receptors (nAChRs) are ligand-gated ion channels whose various subtypes have been targeted in many central nervous system diseases and disorders. The α9α10 nAChR has been implicated as a drug target for neuropathic pain, but very few drug-like and selective ligands have been developed. This research project will fill this gap by developing an α9α10 nAChR-selective antagonist with promising drug-like properties to further study this receptor’s role in neuropathic pain.